Neurocognitive Approaches to Communication Disorders

PROJECT SUMMARY
We propose a renewal of our long-standing training program in Neurocognitive Approaches to Communication
Disorders (now in its 15th year), which currently supports 5 pre-doctoral trainees. This training program is
designed to educate clinically sophisticated scientists who will apply their research skills to the study of
language and communicative disorders, and who will, likewise, apply their clinical acumen to their research
endeavors. The program takes advantage of the rich intellectual resources available in the San Diego region,
and in particular, the SDSU/UCSD Joint Doctoral Program in Language and Communicative Disorders (JDP-
LCD). San Diego has an active research community in this field, with 25 faculty members from SDSU and
UCSD participating in this training program, including 6 new faculty members since the last renewal.
Our interdisciplinary training program, for the next five years, will be headed by our Training Grant
Executive Committee of senior investigators. Our mentor team, drawn from faculty in SLHS, Psychology,
Cognitive Science, Linguistics, Psychiatry and Neuroscience across both universities, has conducted
impactful research on clinically relevant topics, with expertise in a wide range of research methodologies and
clinical populations. The faculty mentors, including rising stars and distinguished leaders in the field, have the
requisite research backgrounds and mentoring skills to support a rich training environment.
The training program will continue to be focused on research with or directly applicable to clinical
populations, while at the same time appreciating basic science underpinnings. To this end, trainees are
required to work with mentors who investigate clinical populations and are required to conduct such research.
Further, trainees are required to get direct experience with two different clinical populations, through
laboratory rotations with their mentors and other faculty. Importantly, for those trainees who chose to become
clinically certified speech-language pathologists, a special clinical track is available.
In support of the growing enrollment in the JDP-LCD, we request 6 pre-doctoral trainees per year for
two-year appointments in this renewal. This would bring us to the original number of trainees provided in
years 1-10 of our program. Our training program has already provided predoctoral training to a substantial
number of highly qualified, diverse scientists. Adding to our existing training program (optional clinic track,
pathway to funding), we propose novel value-added activities to train the Whole Academic. These activities
include professional development seminars and roundtables to encourage clinical and research trainings that
facilitate vertical interactions among students from different years in the program and greater collaboration
amongst researchers with overlapping interest. With rich existing resources and broad commitments from the
program faculty and other university stakeholders to providing advanced training in clinically relevant
research, this training program offers a springboard for future leaders in communication disorders.

Public health relevance
PROJECT NARRATIVE Our program is designed to train clinically savvy, ethical researchers who are prepared to investigate the nature of language and communicative disorders across the lifespan and in diverse populations. In a highly collaborative and interdisciplinary training environment, trainees will develop advanced research skills, acquire clinical perspectives, and pursue professional development. Thus, we will continue to graduate researchers that meaningfully contribute to the fields of communication disorders and related fields.